MARC at Georgia State University

MARC @ Georgia State University (GSU) is a thriving undergraduate (UG) biomedical research training
program for students from underrepresented (UR) groups in STEM, established in 2019 and poised to launch a
new MARC grant from 2024-2029. MARC@GSU has adapted, developed, and implemented evidence-based
approaches to high quality training and mentoring that keep pace with current issues and scientific advances to
develop a diverse pool of UGs who are motivated and prepared for advanced degrees and research careers.
Elements that make our MARC unique are 1) the unusual combination of a research-intensive institution with a
large UG population encompassing a wide range of identities, and 2) a balanced and holistic approach to
research and training that is grounded in education research coupled with the lived experience of students. We
recognize critical barriers to progress in biomedical research such as a lack of diversity of perspectives in the
research workforce that leave health disparities unaddressed, a paucity of forward-thinking UG programs that
create space for students from UR groups to develop confidence in their research acumen, and too few
institution-based strategies to eliminate systemic inequities. Four objectives outline the new MARC Program
Plan: Objective 1. Engage UGs from UR groups in state-of-the-art research through intensively mentored
assistantships at GSU and externships at partner institutions; Objective 2. Enhance the academic environment
at GSU by supporting honors theses, CURE courses, biotech seminars, and an informal graduate school prep
course; Objective 3. Promote acquisition and recognition of the technical, operational, and professional skills
applicable to biomedical PhD programs and beyond, through professional development workshops, research
presentations, and conference travel; and Objective 4. Maximize comprehensive mentoring and provide
individualized career support. Our long-term goal is to equip MARC scholars with the technical, operational,
and professional skills and dispositions for diverse research careers. Our strategic thrust is to leverage GSU’s
existing state-of-the-art research and education programs in six departments (biology, biomedical science,
chemistry, neuroscience, psychology, and public health) to provide research and life skills, along with
explorations of careers in biomedical science, in collaboration with Emory University, Harvard University,
University of Alabama at Birmingham (UAB), and Vanderbilt University. We will evaluate program benchmarks
for progressions toward graduation and advanced degree programs, as well as student development of skills
and dispositions such as scientific research self-efficacy. Ultimately, MARC@GSU will equip and empower
students with the skills and dispositions that will propel them into successful and satisfying careers in the U.S.
biomedical research workforce.

Public health relevance
MARC @ Georgia State University (GSU) is a thriving undergraduate (UG) biomedical research training program for students from underrepresented (UR) groups in STEM, established in 2019 and poised to launch a new MARC grant from 2024-2029. GSU has taken institutional responsibility for ensuring efficient and effective trajectories through undergraduate studies for students from all backgrounds, and MARC lends richness to this college experience through mentored research, enhanced course work, professional development workshops, and career planning. Based on institutional assessment, education science, and lived experiences among students, faculty, and staff at GSU and our partner organizations, the program plan for MARC@GSU is ready to equip and empower students with the skills and dispositions that will propel them into successful and satisfying careers in the U.S. biomedical research workforce.